The Mid-Atlantic Center for Cardiometabolic Health Equity (MACCHE) Diversity Supplement

Summary of the Funded Parent Grant. This proposal is a supplement to a sub-project of
“The Mid-Atlantic Center for Cardiometabolic Health Equity (MACCHE)” (NIMHD
5P50MD017348-02; MPI: Cooper and Crews) entitled “Effectiveness of an evidence-based
health coaching program for reducing cardiometabolic risk among women and infants
enrolled in early home visiting services” (MPI: Bower/Bennett). Black and Latinx women
have the highest prevalence of obesity.1 Women entering pregnancy with obesity have an
excess risk of gestational diabetes, hypertensive disorders, and acute cardiovascular event
during labor and delivery, compared to normal weight women.
2,3
Lifestyle interventions
addressing obesity in pregnancy have the potential to break the cycle of obesity and
cardiometabolic disease (CMD) for Black and Latinx women and their offspring.4 Despite
evidence of effectiveness, few lifestyle interventions have been tested among Black or Latinx
pregnant women or been implemented in community-based settings, where many high risk
pregnant and postpartum women access safety-net services. Early home visiting (HV) is an
evidence-based public health service strategy found in all 50 states that targets services to high-
risk communities to address adverse social determinants of health. Home visitors provide health
education, promote positive parenting and early learning, and link families with needed
community resources.5 This is a hybrid type 1 effectiveness-implementation randomized control
trial comparing the effectiveness of H42/H4U- HV, a remotely delivered evidence-based
pregnancy/postpartum health coaching intervention, integrated into home visiting compared with
usual home visiting services in reducing postpartum weight retention among 360 pregnant and
postpartum women. We will evaluate the implementation of the intervention to enable and
sustain integration into home visiting. H42/H4U-HV, which is tailored for Black, Latinx, Spanish
speaking women and implemented into early home visiting programs has potential to promote
healthy lifestyle behaviors and eliminate disparities in obesity, adverse pregnancy outcomes,
and long-term CMD among young high-risk Black and Latinx pregnant and postpartum women
and their infants. We aim to only establish the effectiveness of H42/H4U-HV but also
understand the factors that enable intervention implementation to inform sustainability, further
the pathway from evidence translation into practice, and facilitate greater subsequent public
health impact.6

Public health relevance
PROJECT NARRATIVE Black and Latinx women are disproportionately burdened by maternal mortality, partly due to disparities in risk of obesity-related co-morbidities and complications like type 2 diabetes, gestational diabetes, and hypertension. Widespread implementation of evidence-based healthy lifestyle interventions designed to reduce these risks can help advance maternal health equity. We propose to engage stakeholders to understand women’s preferences for Healthy for Two Home Visiting, a health coaching program integrated in community-based settings for low-income high-risk pregnant and post-partum women, to enhance program uptake and ultimately reduce maternal health disparities.